Role of integrins in HIV/SIV transmission across cervico-vaginal mucosa

DESCRIPTION (provided by applicant): HIV is most commonly acquired by mucosal route during sexual intercourse. Therefore, blocking this means of transmission will rapidly decrease HIV incidence worldwide. In the first days following mucosal exposure HIV must overcome numerous barriers offering a window of opportunity to act before HIV establishes infection. Unfortunately, the critical events that take place after viral exposure are poorly understood. We propose that HSV-2 influences these early events by modulating the mucosal microenvironment and, to explore how, we will use our recently established macaque model of HSV-2 infection in combination with a model of SHIV vaginal transmission. This combination constitutes a new powerful tool to study the earliest stages of SHIV infection in a controlled manner, explore the effect of HSV-2 and identify the events that influence transmission. Interestingly, we found that rectal HSV-2 infection increases the percentage of α4β7highCD4+ T cells in the site of infection (rectal tissue), blood, and draining lymph nodes. And in earlier wors we described a specific interaction between the HIV/SIV envelope and α4β7. Mucosal CD4+ T cells expressing high levels of this receptor (α4β7high) constitute a preferential target for HIV infection. Recent data has further indicated that early-transmitted viruses exhibit increased reactivity for α4β7 (compared to chronic isolates and to their reactivity for CD4), suggesting that this molecule is especially important during the initial stages of infection. Additionally, we foun that dendritic cells (DCs) infected with HSV-2 in-vitro expand the α4β7high subset of CD4+ T cells in co-culture and increase HIV infection in these mixtures. Thus, we hypothesize that HSV-2 influences DC function within the cervico-vaginal tissue and that this, in turn, increases the presence of α4β7highCD4+ T cells in the mucosa. We intend to use HSV-2 as a tool to dissect the role of α4β7highCD4+ T cells during early events of HIV transmission across the cervico-vaginal mucosa. We will study how HSV-2 modulates T cell and DC biology within the cervico-vaginal tissues (cell migration, activation, phenotype) to determine how this influences susceptibility to repeated low-dose SHIVSF162P3 vaginal challenge. Moreover, using a drug that specifically inhibits HIV-envelope binding to α4β7 versus a mutant virus that has increased affinity for α4β7 we will further demonstrate the importance of the α4β7-HIV interaction in the onset of SHIV infection. These studies will provide critical insight into the role of α4β7 in the earliest moments of HIV infection across the cervico-vaginal mucosa and how this is influenced by HSV-2 infection, opening up novel approaches to tackle HIV spread.

Public health relevance
We believe that the receptor α4β7, present on cells preferentially infected by HIV, has a critical role in HIV-1 transmission. In order prove our hypothesis we will use three different strategies, all of them involving a monkey model of HIV infection. We will study the effect of increasing the % of cells T expressing this receptor in the genital tract right before transmission, we will test a drug that blocks HIV interaction with α4β7 and we will compare the infections of 2 HIV viruses that differ only in the strength of their binding to α4β7. Our work aims to identify a novel target for blocking HIV transmission.